Advancing Psychosocial & Biobehavioral Approaches to Improve Emotional Well-Being

Advancing Psychosocial & Biobehavioral Approaches to Improving Emotional Well-Being
PROJECT SUMMARY/ABSTRACT
Given rising levels of global stress, exacerbated by the pandemic, loneliness and mental health
problems are on the rise, adding to the burden of chronic diseases. Most health-oriented research takes a
harm-reduction approach, identifying and mitigating problems to reduce disease burden. Recent research has
demonstrated that a greater focus on emotional well-being may provide another critical strategy for reducing
disease burden and lead to significant improvements in population health. To advance the science and provide
the strongest evidence base for practice, greater development of research capacity for studying emotional well-
being (EWB) is needed. Core elements of emotional well-being (EWB)--hedonic, evaluative, and eudaimonic--
are associated with better healthspan and are hypothesized to play a causal role. Our overall aim is to create
a cohesive transdisciplinary network of scientists engaged in mechanistic intervention-relevant
research on EWB, with a specific focus on eudaimonia, and pathways by which EWB leads to healthy
longevity, including social connection, positive physiology, and healthy behaviors. We bring together three
leading institutions in EWB science, uniting UCSF (Epel, Mendes), Lee Kum Sheung Center for Health and
Happiness at Harvard (Kubzansky) and UC Berkeley (Keltner, Simon-Thomas) and its interdisciplinary Greater
Good Science Center (GGSC), whose digital platforms reach several millions annually (researchers,
educators, health professionals). We will catalyze innovation and progress of mechanistic research on EWB by
fostering a scientific community focused on measurement and intervention.
Our aims include Aim 1) Facilitating analysis of EWB and healthspan across national cohort studies
in 30 nations that are part of the Health and Retirement Study Family of Studies by harmonizing existing
measures of EWB (e.g., life satisfaction, eudaimonic well-being, positive affect) and supporting causal-
inference analyses; Aim 2) Promoting early stage intervention research by developing sensitive EWB
measures, and interventions that can increase EWB and drive change in relevant biobehavioral mediators
including positive physiology profiles, leveraging existing technology and validated biosensors that measure
autonomic nervous system and sleep; and Aim 3) Creating and disseminating valuable research resources
for studies of EWB and physical health, including a) making the harmonized EWB data across countries
publicly available and providing pilot funding and senior scientist expertise to support investigator time to use
the data; b) creating an expert consensus toolbox of EWB measures and methodology; and c) developing a
library of empirically-validated EWB interventions (building on UCB's repository). After 4 years, the EWB
network will have built strong research capacity and catapulted the field forward with innovative unifying
models, consensus measurement and intervention resources, and mechanistic pilot data. Transdisciplinary
collaborations will continue to generate key findings well beyond the network's input.

Public health relevance
PROJECT NARRATIVE While emotional well-being (EWB) promotes positive health across the lifespan, little is known about how to best increase EWB in ways that lead to downstream improvements in health. The goal of this network is to develop research resources and foster a cohesive community of interdisciplinary scholars focused on discovering which aspects of EWB are most tightly linked to physical health, which interventions most effectively increase EWB, and the biobehavioral processes that explain how EWB impacts health. The network leadership team unites three major research institutions (UCSF, Harvard, UC Berkeley), bringing together the infrastructure and scientific expertise in measurement, intervention development, and dissemination, needed to advance the science of well-being and health.